New Methods for Nitrogen and Oxygen Heterocycle Synthesis

Project Summary/Abstract
The efficient production of small organic molecules and chemical processes impacts pharmaceutical research,
both drug discovery and process chemistry. Chiral compounds make up a substantial portion of bioactive small
organic molecules. Their enantioselective synthesis minimizes use of chiral separation technology, which can
be time and resource intensive, and the production of undesired enantiomers, which are often considered
chemical waste. New copper-catalyzed alkene difunctionalization reactions that enable efficient and
stereoselective synthesis of chiral amine derivatives and ethers, including saturated heterocycles, are being
developed. The products of these reactions readily map on to structures contained in bioactive organic small
molecules such as natural products and pharmaceuticals. In Aim 1, enantioselective aerobic copper-catalyzed
alkene oxidative difunctionalizations will be explored for the direct synthesis of 2-formyl pyrrolidines and 2-formyl
tetrahydrofurans. Application of these aerobic cyclizations to the streamlined synthesis of bioactive natural
products and small molecule intermediates useful to drug discovery will test the practical utility of the methods.
The focus of Aim 2 is the development of methods for the enantioselective synthesis of chiral bridged bicyclic
ketals and other saturated heterocycles that contain fully substituted carbon stereocenters. A number of these
transformations are enabled by a radical group transfer strategy. Mechanistic aspects of these reactions will be
explored, which will enable their rational optimization and predictable application. The focus of Aim 3 is on the
development of copper-catalyzed 2- and 3-component reactions that involve the coupling of alcohol and amine
derivatives with styrenes or dienes, and alkyl radicals formed in situ. Mechanistic aspects of these reactions,
especially related to stereoselectivity, will be investigated. Development of these chemical transformations will
enable their use in multi-step organic synthesis in drug discovery and chemical biology applications. Their
invention enables new options for synthetic organic chemists, which may enable diverse small molecule
candidates to be synthesized efficiently. Lessons learned in reaction engineering for efficiency and selectivity
will be applicable to the invention and development of related useful chemical processes.

Public health relevance
Project Narrative Organic molecules containing oxygen and nitrogen are ubiquitous in biomedical research and in the treatment of a range of human ailments including mental health conditions, cancer and diabetes as well as cardiovascular, infectious and neurodegenerative diseases. This project is centered on the development of efficient, catalytic and stereoselective methods for C-O, C-N and C-C bond formation, useful in the efficient construction and structural optimization of bioactive compounds. These methods will facilitate drug discovery by enabling the synthesis of new, potentially useful, small molecules, as well as pharmaceutical process development, by enabling the streamlined synthesis of known bioactive compounds.